REGIONAL CEREBRAL CIRCULATION AND METABOLISM

The deoxyglucose method for the quantitative determination of rates of local glucose consumption in the discrete functional and structural components of the brain of conscious or anesthetized laboratory animals was developed in this laboratory over 10 years ago. In this method (14C)deoxyglucose is employed as a tracer for glucose flux through the hexokinase step; the product, (14C)deoxyglucose-6-phosphate, is measured by quantitative autoradiography. The method continues to be used to study alterations in local energy metabolism in a variety of physiological, pharmacological and a limited number of pathological states. Its suitability to a wider range of pathologic conditions is being extended and special time constraints which may be present in the method's adaptation for use in human subjects with (18C)fluorodeoxyglucose and PET have been examined.